ENDOCRINE EVALUATION OF PANCREATIC TRANSPLANT

Type I diabetics undergoing pancreatic transplantation surgery are studied pre and immediately post surgery, and in longterm followup to (1) study the impact of physiologic regulation of glucose insulin kinetics and metabolic control (2) provide data on endocrine markers to identify early rejection of the transplanted pancreas, and (3) study the endocrine responses to various stimulatory tests on denervated, systemically drained, pancreas preparation.